Core 1: Design and Optimization Core (Optimization Core)

Project Summary
A primary aim of the proposed Program Project is to develop an optimized healthcare system smoking
program (the Comprehensive Chronic Care Smoking Treatment Program: CCCSTOP). This will be
accomplished using the Multiphase Optimization Strategy (MOST), an engineering-inspired methodological
framework for developing, optimizing, and evaluating multicomponent treatments. The Design and
Optimization Core serves the Program Project by providing a centralized resource for expertise and support
pertaining to this innovative approach. The Specific Aims will be: 1) To support and serve as an intellectual
resource for the application of MOST to develop, optimize, and evaluate CCCSTOP. To conduct the research
proposed in this Program Project application, it will be necessary to integrate data and substantive knowledge
about smoking cessation with methodological expertise on topics such as efficient experimental design and
statistical analysis. It will also be necessary to engage in complex decision-making based on the results of
experimentation. This core will promote, support, and coordinate these efforts, working closely with the Data
Analysis Core. 2) In concert with other project investigators, to refine and further develop the MOST framework
and related methodological tools to enhance the work of this Program Project. One area of refinement is the
application of ideas and procedures from decision analysis, to expand the application of MOST to more
realistic—but also more complex—situations in which multiple outcomes are considered in the identification of
an optimized treatment strategy (e.g., by using multiple criteria decision analysis). This procedure will be
implemented in this project, and will serve as a resource for others who are optimizing interventions in cancer
prevention and treatment where interventions target more than one outcome. 3) To disseminate the MOST
approach and related methodological tools to the cancer control research community. The refined decision-
making procedure and related methodological tools will be disseminated via journal articles, talks, workshops,
and training activities to scientists and clinicians not only in the smoking cessation area but also in other areas
of cancer prevention and treatment.

Public health relevance
Project Narrative The Optimization Core is devoted to the implementation, advancement, and dissemination of engineering- inspired research methods for making behavioral treatments more effective. These methods have the potential to hasten the development of more effective and efficient smoking cessation treatments that can help more smokers to quit smoking permanently and substantially reduce their cancer risk.